University of Pennsylvania Diabetes Research Center

SUMMARY
The Penn Diabetes Research Center (DRC) participates in the nationwide interdisciplinary program established
over four decades ago by the NIDDK to foster research in diabetes and related metabolic disorders. The mission
of the Penn DRC is to support and develop successful approaches to the prevention, treatment, and cure of
diabetes mellitus. Administered by the University of Pennsylvania, the Penn DRC currently serves 134 diabetes-
oriented investigators, primarily from the Perelman School of Medicine at the University of Pennsylvania School
but also from other Schools within the University as well as collaborating local institutions including Thomas
Jefferson University, Temple University School of Medicine, the Monell Chemical Senses Institute, the Wistar
Institute, Drexel University, and Rutgers University. Overall direct costs of $89M support the work of these
investigators. The Penn DRC is highly interactive and interdisciplinary, representing many basic science and
clinical departments. The Research Base of the Penn DRC is organized in 4 Units: 1) Type 1 Diabetes, with a
focus on beta cell biology and Pathology; 2) Type 2 Diabetes, focused on signaling by insulin and other
hormones; 3) Obesity; and 4) Complications. The Complications Unit includes Programs in Cardiovascular
Metabolism and Diabetic Nephropathy. The Penn DRC facilitates and supports diabetes research in a variety of
ways. Six Biomedical Research Cores facilitate the work of Penn DRC investigators: Functional Genomics Core;
Islet Cell Biology Core; Rodent Metabolic Phenotyping Core; Radioimmunoassay/Biomarkers Core; and
Transgenic Mouse Genome Editing Core. Collaborative research and application of emerging technologies to
diabetes investigation are further promoted by the Regional Metabolomics and Fluxomics Core at Princeton. A
Pilot and Feasibility Grant Program that has been highly successful over decades serves to nurture new
investigators and to foster new initiatives in diabetes research. A broad and intensive Enrichment Program
organizes weekly Diabetes and Endocrinology Research seminars, special events, and an annual Spring
Diabetes Symposium, all designed to enhance communication and collaboration of Penn DRC investigators
while keeping them abreast of the latest discoveries. Penn DRC investigators mentor trainees at every level
(undergraduate, predoctoral, and post-doctoral Ph.D., M.D., and combined M.D./Ph.D.), and the Enrichment
Program provides a superb environment for training in diabetes research. The Biomedical Cores, Pilot and
Feasibility Grant Program, and Enrichment Program are coordinated and publicized by an Administrative Core
that governs the DRC. Its organizational structure, including the Director and Associate Directors, Executive
Committee, Committee of Core Directors, Academic Enrichment Program Directors, and external as well as
internal advisory boards, functions to maintain the diabetes-related research at the Penn DRC at the forefront of
biomedical science.

Public health relevance
PROJECT NARRATIVE It is estimated that 25.8 million people in the United States (8.3 percent of the population) currently have diabetes, and the rate is higher among the elderly and Hispanics, Native Americans, and African-Americans. The mission of the Penn Diabetes Research Center is to prevent and cure this devastating disease and its complications through interdisciplinary basic and translational research.